PDE5 INHIBITION AS ADJUNCTIVE MEDICAL THERAPY IN AORTIC STENOSIS

DESCRIPTION (provided by applicant): This proposal describes a 3-year research and training program that will allow Dr. Brian Lindman to develop into an independent clinical translational investigator with a focus on calcific aortic stenosis (AS). The unmet scientific and clinical needs for AS were what ignited Dr. Lindman's desire to pursue an investigator path. The emphasis of the award application is Dr. Lindman's development as an investigator who will be able to advance our understanding of the pathophysiology of AS, identify novel and promising targets for medical therapy, and design and execute proof of concept clinical trials with surrogate endpoints that pave the way for larger trials with clinical endpoints. The research aims, career development activities, and mentorship team have been designed to fill particular educational and experiential gaps in Dr. Lindman's training. Career Goals: * To become a productive, independent clinical translational investigator who makes a significant contribution to our understanding of AS, with the intent of changing our clinical practice in ways that improve patient outcomes. * To elucidate the adverse impact of and mechanisms contributing to ventricular and vascular remodeling in patients with AS. * To identify and test novel medical therapies for AS Environment and Career Development Plan. At an institutional level and specifically within the cardiovascular division, Washington University provides an incredibly rich and supportive intellectual and collaborative research environment with ample resources and opportunities available for Dr. Lindman to successfully accomplish his research and career development goals. The mentorship team represents a multidisciplinary group of individuals specifically chosen to complement one another with the PI's particular scientific and career development goals carefully considered. The primary mentor is Douglas Mann, MD, an internationally recognized expert in heart failure, who has a long track record of translating basic science discoveries into clinical trials and identifying novel targets for therapy. The Institute for Clinial and Translational Sciences (CTSA funded) provides extensive opportunities for collaboration, has energized clinical and translation research at Washington University, and provides numerous core facilities to streamline research activity. The career development plan includes coursework, conferences, and several tailored practical learning experiences combined with specific activities to apply the knowledge gained. Collectively, these should complement the research aims to address gaps in the PI's training and knowledge to enable him to pursue his research studies independently. Research plan. The focus of the management and treatment of AS has traditionally been limited to the valve, causing us to often treat the valve rather than the patient. However, it is nw clear that maladaptive remodeling in the ventricle and vasculature contribute substantially to the morbidity and mortality of the disease. Emerging preclinical and clinical data suggest that phosphodiesterase type 5 (PDE5) inhibition may help in this regard. During the recent period of KL2 support, the PI made the novel observation that a single dose of a PDE5 inhibitor is safe and well-tolerated in patients with severe AS and is associated with acute improvements in pulmonary and systemic hemodynamics, resulting in biventricular unloading. This finding raises the interesting possibility that PDE5 inhibitors may be useful as adjunctive medical therapy in AS by unloading the left and right ventricles, improving abnormal hemodynamics, and stabilizing heart failure symptoms prior to more definitive therapies for AS. In this application, the PI proposes to build upon the findings of the single-dose study by conducting two longer term clinical studies that are intended to explore the possibility that adjunctive medical therapy with PDE5 inhibition will improve clinical outcomes in patients with AS. The proposed studies will test the role of PDE5 inhibition in patients with AS using surrogate endpoints, laying the foundation for future studies evaluating patient-centered, clinical endpoints. Aim 1 will evaluate short-term (2 weeks) PDE5 inhibition in patients with symptomatic AS to see whether it can provide sustained hemodynamic benefits, which could serve as a stabilizing bridge to definitive therapy with valve replacement. Aim 2 will evaluate chronic (6 months) PDE5 inhibition in patients with asymptomatic AS to see whether this therapy could decrease hypertrophic cardiac remodeling and improve ventricular function, which may delay symptom onset and prepare the ventricle better for surgery. Aim 3 will evaluate a novel MRI sequence to assess cardiac fibrosis, which may improve our risk stratification of patients with AS and provide a non- invasive tool for assessing the response to anti-fibrotic therapies. The proposed studies combined with the planned career development activities will prepare the PI to pursue future clinical studies evaluating adjunctive medical therapy in the treatment of AS independently, employing PDE5 inhibitors and other emerging therapies.

Public health relevance
Project Narrative Calcific aortic stenosis is a common heart valve disease of the elderly that causes significant morbidity and mortality. Valve replacement surgery is currently the only treatment for aortic stenosis, but changes in the heart muscle and blood vessels brought on by the valve stenosis increase surgical risk and limit symptomatic improvement after surgery. The research proposed will begin to test whether adjunctive medical therapy with phosphodiesterase type 5 inhibitors can improve the clinical management of patients with aortic stenosis. __SpecificAimsTextDelimiter__ Specific Aims Calcific aortic stenosis (AS) remains a surgical disease in 2012. No medical therapy has been proven to delay/reverse the progression of disease, symptoms, or time to valve replacement. Although attempts at medical therapy have focused on slowing progressive stenosis of the valve, it bears emphasis that AS is more than simply a disease of the valve, insofar as the pressure overload from valve stenosis leads to progressive remodeling and dysfunction of the left ventricle (LV) as well as abnormal hemodynamics that contribute to significant morbidity and mortality. During the recent period of KL2 support, the PI made the novel observation that a single dose of a phosphodiesterase type 5 (PDE5) inhibitor is safe and well-tolerated in patients with severe AS and is associated with acute improvements in pulmonary and systemic hemodynamics. Although the improvements in pulmonary hemodynamics were expected, we also observed an unanticipated unloading of the LV (decreased preload and systemic afterload) that was associated with an increase in stroke volume. This finding raises the interesting possibility that PDE5 inhibitors may be useful as adjunctive medical therapy in AS by unloading the left and right ventricles, improving abnormal hemodynamics, and stabilizing heart failure symptoms prior to more definitive therapies for AS. Moreover, although speculative, experimental pressure overload studies and emerging clinical studies with PDE5 inhibition in non-AS heart failure populations raise the interesting possibility that longer-term treatment with PDE5 inhibitors may potentially improve surgical outcomes by favorably remodeling the ventricle and pulmonary vasculature prior to surgery. Accordingly, in this K23 application, the PI proposes to build upon the findings of the single-dose study by conducting two longer term clinical studies that are intended to explore the possibility that adjunctive medical therapy with PDE5 inhibition will improve clinical outcomes in patients with AS. It is anticipated that these pilot studies will provide the necessary proof of concept data that will allow the PI to design future larger trials with clinically meaningful endpoints in patients with advanced AS. Three specific aims are envisioned. 1. Evaluate the safety and tolerability of short-term PDE5 inhibition and determine whether it can provide sustained hemodynamic improvement in patients with severe symptomatic AS (PODCAST). We will randomize subjects (n=32) with severe AS, advanced heart failure symptoms (NYHA III/IV), and pulmonary hypertension to 2 weeks of PDE5 inhibition vs. placebo and measure invasive hemodynamics, quality of life, and echocardiographic indices of diastolic and systolic function. Hypothesis: Treatment with a PDE5 inhibitor will be safe and well-tolerated, provide sustained hemodynamic benefits, and improve quality of life. Potential impact: There has been no oral therapy available to improve the clinical and hemodynamic state of patients with symptomatic AS and advanced heart failure symptoms. Such adjunctive medical therapy could serve as a stabilizing bridge to definitive therapy with valve replacement. 2. Evaluate the tolerability of chronic PDE5 inhibition and its effects on LV structure and function in patients with moderate to severe asymptomatic AS (ASPEN). We will randomize asymptomatic subjects (n=24) with moderate or severe AS and evidence of LV hypertrophy and diastolic dysfunction to 6 months of PDE5 inhibition vs. placebo and evaluate them before and after with cardiac MRI and echocardiography to examine the effects on LV mass and function. Hypothesis: Chronic PDE5 inhibition will be associated with decreased LV mass and improved diastolic and systolic function. Potential impact: Medical therapy to prevent/reverse maladaptive LV remodeling and its functional consequences may alter the clinical management of patients with AS and improve outcomes. If this pilot study is positive, it would provide the rationale for a longer-term study to determine whether targeting ventricular remodeling in AS will delay the time to symptoms and/or valve replacement and improve post-operative outcomes. 3. Evaluate a novel cardiac MRI sequence to assess ventricular fibrosis in patients with AS. We will perform cardiac MRI employing a T1 mapping sequence (novel) and late gadolinium enhancement (LGE) (current standard) to measure cardiac fibrosis in patients who will provide an LV tissue specimen at the time of surgery (3a) and in patients enrolled in the ASPEN study (3b). T1-derived indices of fibrosis (T1 time and extracellular volume fraction) as well as % area LGE will be correlated with the % area of collagen in cardiac specimens and will be used to determine whether chronic PDE5 inhibition prevents/reverses cardiac fibrosis in patients with AS. Hypothesis: There will be a significant correlation between the amount of cardiac fibrosis detected by T1-derived MRI indices of fibrosis and the direct measure of collagen, which will be stronger than the correlation between % area LGE and collagen content. Furthermore, we hypothesize that PDE5 inhibition will decrease cardiac fibrosis in patients with AS in the ASPEN study. Potential impact: A non-invasive imaging tool to quantify fibrosis could alter our risk stratification of patients with AS and provide a tool for measuring the response to anti-fibrotic therapies.